Administrative Core

ABSTRACT—ADMINISTRATIVE CORE
UC Davis has long-standing experience providing expert administrative leadership and management of large
NIH-funded resources serving the broader research community. Since 1997, these activities have been
centralized under the UC Davis Mouse Biology Program (MBP), a campus program that provides
administrative oversight and management of resources associated with the creation, maintenance, and
phenotyping of mouse models used in biomedical research. Ten years ago, MBP administrative structure and
organization was adapted to create and implement a dedicated administrative core for the highly successful
NIDDK-funded Mouse Metabolic Phenotyping Center (MMPC) at UC Davis. As NIH sunsets the MMPC
Program to make way for a new National MPMOD Program, we will adapt approaches successfully applied to
operating the MMPC to establish an Administrative Core to serve the leadership, management, and
organizational needs of the MPMOD Center at UC Davis. The Administrative Core will be staffed by a Leader,
co-Leader, Project Navigator, a Business Manager, a Head of Information and Data Management, and a
Biostatistics and QA/QC Officer. A Local Center Steering Committee made up of senior Center leadership and
a non-affiliated senior researcher will provide scientific guidance and oversee Center administration and project
management.
To accomplish this activity, the Administrative Core will pursue the following 3 Specific Aims:
Specific Aim 1: Assemble an Administrative Plan for the Center.
Specific Aim 2: Establish and execute a Service Plan for the Center.
Specific Aim 3: Implement a Business Plan for the Center.
By facilitating operational effectiveness and efficiency, the Administrative Core will contribute to the success of
the Center and the National MPMOD Program.